A Treg cell-intrinsic CTLA4-PKC-eta signaling pathway mediating contact-dependent suppression of tumor immunity: A novel target for cancer immunotherapy

ABSTRACT
Regulatory T cells accumulate and correlate with poor prognosis in many cancers, and ablation of Treg
together with other therapies is being explored in the clinic. The success of this approach requires, however,
elucidation of the mechanisms of regulation and action of Treg in order to provide new, more selective targets
for rational immunotherapy. This proposal derives from our discovery of a novel Treg-intrinsic signaling
pathway required for contact-dependent suppression of tumor immunity. In this pathway, Treg-expressed
CTLA4 physically associates with protein kinase C-eta (PKCη) and, upon CTLA4 engagement, recruits a PAK-
PIX-GIT complex required for focal adhesion disassembly. PKCη deletion or expression of a CTLA4 non-
interacting PKCη mutant impaired Treg ability to inhibit tumor-specific immunity, but not autoimmune colitis.
We hypothesize that this novel CTLA4 signaling axis is obligatory for contact-dependent suppression of tumor
immunity by Foxp3+ Treg. Our overarching goal is to further explore at the mechanistic and animal levels this
signaling pathway and its functional implications for tumor immunity. In Aim 1, we will mechanistically analyze
the molecular pathways utilized by CTLA4 and PKCη to recruit and activate the GIT2-PAK2-αPIX complex and
mediate contact-dependent suppression in mouse and human Treg, and determine how disruption of this
signaling pathway affects Treg suppression. We will also use 2-photon microscopy to study intratumoral Treg-
DC dynamics. Given the critical role of CD8+ T cells as tumor-killing CTL, we will also determine how CD8-
specific PKCη deletion affects their activation and functions. In Aim 2, we will use mice with constitutive, Cre-
mediated deletion of PKCη (and GIT2) in Foxp3+ Treg to analyze in vivo how disrupting CTLA4-PKCη
signaling affects tumor immunity and the tumor microenvironment. We will use preclinical tumor models,
including a melanoma carrying the BrafV600E mutation and a genetically engineered mouse hepatocellular
carcinoma model. We will focus on tumor-infiltrating Treg, CD8+ cells and DC, and explore the
transendocytosis pathway of Treg-mediated depletion of costimulatory CD80/CD86 ligands from antigen-
presenting cells, which is impaired in Prkch–/– Treg. If Aim 1 studies reveal an important role for PKCη in CD8+
T cells, we will additionally analyze tumor growth and the tumor microenvironment in mice with CD8-specific
Prkch deletion. In Aim 3, we will use mice with a tamoxifen (Tam)-induced, time-controlled Treg-specific
PKCη deletion, either alone or in combination with adjunct therapies, to study the therapeutic effects of these
manipulations, using the tumor models in Aim 2. The studies will benefit from availability of all tools and models
and from expert collaborators. We expect this project to provide mechanistic understanding of a novel pathway
that Treg utilize to suppress tumor-specific immunity and promote tumor growth. This understanding could lead,
in turn, to novel cancer immunotherapies based on selective inactivation of the CTLA4-PKCη signaling
pathway in Treg, resulting in inhibition of cancer-promoting Treg with minimal autoimmune-related side effects.

Public health relevance
NARRATIVE Immune system cells called regulatory T cells (Treg) function to dampen excessive, potentially harmful immune responses such as autoimmune diseases, but their accumulation in cancers generally inhibits effective tumor- specific immune responses that are necessary in order to eliminate growing tumors. Therefore, strategies to eliminate or inhibit the function of Treg in cancer are actively being sought. In this project, we will explore how an enzyme - protein kinase C-eta - that we found to be required for the immune suppressive activity of Treg regulates this activity, and determine whether strategies that eliminate this enzyme or prevent its interaction with another functionally important Treg surface protein (CTLA4) in Treg improve the ability of the immune system to inhibit cancer growth in preclinical mouse models.